Administrative Core

TBRU Administrative Core (Admin Core)
The proposed TBRU application will be supported by an Administrative Core structure to assist, coordinate
and maintain the TB Research Unit, the unit's research and development progress, communications, interactions
with internal and external partners and provide problem resolution. The Admin Core and Data Center will sit
physically within a dedicated suite and share infrastructure and facilities developed for TB research in the
International Center for Public Health (ICPH) building on the Rutgers-NJMS campus. Core lead is Dr. Alland,
with Co-Leads - Mr. David Hom and Ms. Francesca Escaleira.
Specific Aims:
1. Develop and operate an administrative (fiscal, regulatory), operational (scientific, logistics) infrastructure
and data management center capable of supporting proposed clinical, animal & translational protocols.
2. Maintain fiscal compliance and site reimbursement procedures per NIH policy.
3. Communicate and work with NIH program staff to monitor study progress and achieve milestones.
4. Coordinate and collaborate with other TBRU programs to leverage expertise across network.
A Management Plan and system will be deployed to maintain the operations of the TBRU, including the
financial, administrative/regulatory compliance activities, communications within the Unit, its committees and
with TBRU-N, programmatic DMID and TBRU meetings, sponsor interactions, progress reports, supplement
submissions, and assist Principal Investigators with project assessments. Appropriate and experienced
financial analyst, administrative coordinator are available for program conduct and post-awards management.
An existing Data Center - Data and Operations Management Center (DOMC) in the Center for Emerging
Pathogens (directed by Dr. David Alland) will provide a comprehensive Data Management Plan with
appropriate systems to organize, coordinate and validate the collection of clinical data, specimens (MTB
strains and blood samples) from the proposed clinical protocols. The DOMC houses trained, experienced
staff, who have worked in Uganda and Brazil in clinical studies. Validation and management of data collected
will be maintained by the Data Center, monitored by the Clinical Core. A specimen repository system
(FreezerPro web-based platform) will be maintained for collected MTB strains and blood samples (described
in Clinical Core). The DOMC will also assist with the collection of basic and translational data from TBRU
investigators to help with data management and structure required by the Systems Biology Core for statistical,
genomic, and systems biology analytic approaches.